Unusual Pharmacophores and New Tools for Cross-Coupling

Abstract of “Unusual Pharmacophores and New Tools For Cross-Coupling,” 5R35GM122606
Bioassay-guided fractionation of cells uncovers small molecules that bind receptors in new and
unexpected ways. These cellular metabolites emerge from evolution with complex molecular features
preoptimized for function. High stereochemical content, high globularity and diverse heteroatom content
impart greater specificity of protein binding and greater aqueous solubility than simple, flat and non-polar
substances. Parametrization of large molecular libraries have supported a correlation between evolutionary
optimization and therapeutic design: “drug” chemical space is optimized away from commercial building
blocks and towards natural products (NP space). These types of molecules represent a challenge to chemical
synthesis, however, and require the development of new chemical tools for optimization and human use.
This grant advances our work towards the rapid access and navigation of NP space. Our robust
routes to complex molecules have proven practical: synthesis allowed us to annotate and modify biological
function. Over the coming grant period we extend this approach into three areas. First, we develop the
chemistry to access two chemotypes with known phenotypic effects but unknown biological targets. One
target has stimulated the discovery of a new, stereoselective cross-coupling reaction, whereas another has
inspired the conversion of inert scaffolds to new warheads for protein adduction. Second, we describe rapid
access to complex ligands of known biological targets that embody ‘combinatorial’ aggregates of multiple
proteins. Diverse structural modifications of the complex small molecule will enable a search for selectivity
among these combinatorial targets with consequences for therapeutic development. Third, selectivity
defines the future goals of dual-catalytic cross-couplings to reach NP space: we seek to address substrate
selectivity, relative stereoselectivity and absolute stereoselectivity.

Public health relevance
Project Narrative Natural product chemical space (NP space) embodies small molecules that are preoptimized for organismic compatibility. This proposal describes the invention of new chemistry to access, interrogate and modify secondary metabolites that already demonstrate neuromodulatory or antiproliferative phenotypes. These studies lay the foundation for the development of new tools to study human disease and new therapeutics to alleviate it.